Development of a proteomic assay for monitoring transplanted cells and tissues

Many chronic disease states may be treatable with emerging regenerative medicine strategies, such as cell
replacement and artificial tissues, however, no tests exist for measuring the success of these ground-breaking
therapies. For example, liver disease is a large unmet medical need for which the only effective therapy is liver
organ transplantation. Transplantation of hepatocytes as a cell suspension rather than transplantation of the
whole organ has the potential to provide an alternative therapy that would make the benefits of organ
transplantation available to many more patients than currently benefit. This approach has been demonstrated
to be feasible in animal models. The success of hepatocyte transplantation in animal models is measured by a
blood test. No such test exists to measure success of hepatocyte transplantation in humans. The proposed
project will develop a simple blood test for successful transplantation of human hepatocytes in human patients,
enabling clinical development of this therapy. The fundamental principle we are building this test on is the ability
to detect using mass spectrometry methods differences in the amino acid sequence of secreted donor
hepatocyte proteins from the same proteins derived from patient hepatocytes. This strategy has the advantages
of rapid assay development, multiplexing, and sensitivity. Preliminary results are presented that demonstrate
successful identification proteins in plasma that can distinguish between individuals and, thus, enable
differentiation between donor and recipient proteins in plasma. The proposed work will complete assay
development for the liver-specific version of this test and validate the test in blood samples obtained from liver
disease patients before and after whole organ transplantation. Phase II of this project will qualify the test for
measuring transplanted hepatocytes in a prospective trial, assess potential utility as a prognostic test for whole
organ transplantation in various liver disease settings, and develop automated and commercializable methods
to facilitate adoption.

Public health relevance
Chronic diseases, including liver disease, affect a large number of people in the United States. Novel therapies based on the principles of regenerative medicine, such as transplantation of stem cell-derived liver cells to replace lost liver cells, are being developed for liver disease and other chronic diseases. Tests to measure the effectiveness of these regenerative medicine-based therapies, such as the proposed proteomic assay of plasma proteins in blood samples, are needed to derive the most value out of these novel therapies.